The role of gut microbe-derived choline metabolites in driving the pro-inflammatory macrophage phenotype and restricting pancreatic cancer

PROJECT SUMMARY
The treatment of pancreatic ductal adenocarcinoma (PDAC) remains a major hurdle, with a 5-year survival
rate of only 9%. Resistance of PDAC to chemotherapy and immunotherapy is thought to arise primarily due
the immunosuppressive tumor microenvironment (TME), characterized by a dense fibrotic stroma and high
infiltrates of immunosuppressive cells, including tumor associated macrophages (TAM). TAMs block effector
T cell function and trigger exhaustion. Immune responses in the TME are likely controlled by multiple
mechanisms, including host intrinsic factors and, more recently appreciated, changes in the gut microbiome.
However, the molecular mechanisms and pathways by which the gut microbiome impact the immune
responses in the PDAC TME remain poorly understood. Our new preliminary work indicates that the gut
microbiota can influence the immune response through microbial metabolites that enter the blood stream to
modulate TAM activity. In an untargeted metabolomic screen on circulating metabolites, we discovered the
most significant change was a dramatic reduction (>80-fold) in trimethylamine N-oxide (TMAO) levels in
PDAC-bearing mice treated with antibiotic metronidazole. TMAO is formed in two steps: the gut microbial
TMA lyase degrades choline to trimethylamine (TMA), which then undergoes oxidation in the liver to form
TMAO. Intraperitoneal administration of physiologically relevant amounts of TMAO to PDAC-bearing mice
significantly suppressed tumor growth. This was accompanied by a significant decrease in tumor-infiltrating,
immunosuppressive myeloid cells, an increase in a pro-inflammatory TAM phenotype, and a striking increase
in infiltrates of activated CD8+ T cells in the PDAC TME. These and other data support our hypothesis that
dietary choline and the gut microbial TMA lyase are key factors contributing to circulating TMAO levels and
the pro-inflammatory TAM phenotype. We propose that supplementing TMAO or enacting strategies that
increase it will improve response to immunotherapy in PDAC. Aim 1 tests the hypothesis that dietary choline
and the gut microbial TMA pathway contribute to the acquisition of a pro-inflammatory TAM phenotype and
induction of anti-tumor immune response. We will employ supplementation of choline diet, depletion of TMA-
producing bacteria, and inhibition of TMA lyase to evaluate the mechanistic links between dietary precursors
of TMAO, the gut microbial TMA pathway, and immune responses in the PDAC TME. Aim 2 tests the
hypothesis that increasing TMAO sensitizes PDAC tumors to immunotherapy. We will evaluate direct
administration of TMAO or enrichment of TMA-producing gut bacteria such as Clostridium sporogenes in
combination with immune checkpoint blockade. This aim will also evaluate the clinical significance of the
TMAO biology by determining the association between plasma TMAO levels and clinical outcome of survival
and disease progression in PDAC. In the longer term, this work may form the basis for developing new,
microbiome-based therapies for the aggressive and hard to treat PDAC.

Public health relevance
PROJECT NARRATIVE Pancreatic ductal adenocarcinoma (PDAC) has the highest mortality rate of all major cancers. Current therapies, including immunotherapy, remain only marginally effective. Therapy resistance is likely caused by the immunosuppressive tumor microenvironment (TME) of PDAC, which is dominated by infiltrates of tumor- associated macrophages (TAM) that restrict cancer killing by effector T cells. The gut microbiome is emerging as a key factor impacting immune responses and response to therapy in PDAC. The main goals of our proposal are to define the molecular links by which the gut microbiome and its associated metabolites control the pro-inflammatory TAM phenotype and to determine how such metabolites can be exploited for therapy.